Cellular and Genetic Basis of Systemic Lupus

DESCRIPTION (provided by applicant): Systemic lupus erythematosus (SLE), a multi-system disorder with significant morbidity and mortality affects predominantly females in their reproductive years. Genetic and environmental factors play significant roles in its pathogenesis. Despite significant progress, immune mediated glomerulonephritis (GN) remains a major cause of end stage renal failure. The PI's laboratory has been focused on the genetic aspect of lupus GN by studying the murine model NZM2328. This competitive renewal application is to continue the PI's research program to identify lupus susceptibility genes, Cgnz1 and Adnz2, on chromosome 1 that confer the production of antinuclear and related autoantibodies (Ab) and end organ resistance to the development of chronic glomerulonephritis (cGN) respectively in NZM2328, a much studied model for human proliferative lupus nephritis. During the currrent grant period, two informative congenic lines, 290-2 and 507-2 were generated and characterized. This analysis led to the conclusion that this region has been narrowed to a 1.34Mb area that is very much amendable to further analysis. The separation of autoimmunity and end organ damage is unique and the PI's laboratory remains the major site to focus on the genes which contribute to end organ resistance to damage. A team of investigators with complementary skills have been assembled to utilize up-to- date techniques in molecular and cell biology and animal genetics to resolve this technically demanding research project. To achieve the long term objective of this program, four specific aims are proposed: Specific Aim 1: To generate and to characterize the NZM.C57Lc1 recombinant congenic strain Lc1(1.34Mb) that contains the 1.34Mb of interest by intercross breeding (NZM2328X507-2)F1 X (NZM2328X507-2)F1; Specific Aim 2: To identify a set of contiguous overlapping genomic clones (contigs) from the NZM2328 BAC library, which cover the 1.34 Mb region of interest and to sequence these contigs to define polymorphisms in this region by comparing the sequences with those of 129 and B6/C57L available in the database. The polymorphisms may also identify potential candidate genes for Cgnz1 and Adaz2; Specific Aim 3: To determine the transcriptional profiles of the 45 genes within this region in intrinsic kidney cells and in immune cells including T and B cells, dendritic cells, monocytes and macrophages and NK cells to identify candidate genes responsible for kidney resistance to damage and for those for enhanced autoimmune response and Specific Aim 4: To validate susceptibility by gene knockin technology or allele transgenesis. The results will provide conclusive evidence that genes controlling end organ damage play an important role in lupus nephritis and that they interact with genes that enhance autoimmunity resulting in various clinical presentations. On the basic level, the results may alter our thinking on the pathogenesis of autoimmune disorders. In addition, these results have significant clinical implication in that genetic factors may allow us to tailor individual therapeutic regimens for lupus nephritis to maximize therapeutic goals and to minimize toxic side effects.

Public health relevance
PUBLIC HEALTH RELEVANCE: Systemic lupus erythematosus is a disease affecting many organs. It causes a significant amount of suffering and early death. It affects predominantly females at their reproductive ages. Genetic factors play a significant role. Despite significant progress in research, renal disease remains a major cause of end stage renal failure that requires either chronic dialysis or renal transplantation. This proposal is to seek funding to continue a research program to identify genetic factors that affect autoimmunity and render the kidney resistant to damage by autoantibodies and/or autoreactive lymphocytes. The research program is taking advantage of the unique mouse models established in the investigators' laboratory. The results of the research program can be readily translated to patient care in that individual patients can be treated with individual regimens for their renal disease and to maintain them in remission. This will reduce the morbidity and mortality significantly so that patients can remain active and productive. Thus the research program should have significant impact on public health. __SpecificAimsTextDelimiter__ RESEARCH PLAN 2. A) Specific Aims: Systemic lupus erythematosus (SLE) is the prototype of immune complex mediated systemic autoimmune disorder. Accumulated evidence indicates that both genetic and environmental factors play interactive roles in its pathogenesis. In the case of lupus nephritis, one of the most devastating complications is chronic renal failure as a result of immune complex-mediated glomerulonephritis (GN). Despite considerable progress in our understanding of the basic mechanisms and the genetic control of the immune response, the pathogenic mechanisms underlying SLE are poorly understood. The main therapeutic approach remains the application of corticosteroid and other general immunosuppressive agents. While these agents are effective in general, they have considerable side effects. In particular, African American patients with lupus nephritis fare less well with the current therapy. The understanding of the genetic basis of SLE may provide a rational basis for specific intervention in this disorder, avoiding the side effects of corticosteroid and general immunosuppressive agents currently in use. Significant progress has been made in the delineation of the susceptibility genes in this disorder. In the mouse, many genes have been identified by linkage studies, knockout technology and transgenesis. In man, multiple genes have been implicated including the MHC complex, genes in the complement pathway and other non-MHC genes and genes in the complement pathways. Despite these advances, the genetic basis of SLE is far from completely understood. In our studies on NZM2328, a mouse model for human proliferative lupus nephritis with many of the characteristics of human SLE, severe proteinuria and chronic GN (cGN) leading to death by 12 months of age are seen predominantly in females although both female and male mice have a similar incidence of anti- nuclear (ANA) and anti-dsDNA antibody (Ab) production. In a backcross analysis of (NZM2328 XC57L/J)F1XNZM2328 mice, a locus on chromosome 4, Adaz1 was identified to be linked to ANA and anti- dsDNA Ab production. A locus, Cgnz1 controlling cGN was mapped to chromosome 1. In addition, a distinct locus, Agnz1, which is separated from Cgnz1 in location and contributes to acute GN (aGN) was also identified to this region of Chromosome 1. Two congenic strains, NZM2328.C57Lc1 (Lc1) and NZM2328.C57Lc4 (Lc4) have been generated by introducing either the genomic segment around D1Mit36 or that around D4Mit175 from C57L/J to NZM2328 by the method of rapid congenic development. In Lc1, C57L/J derived heterozygosity is sufficient to abolish ANA and anti-dsDNA Ab production and to prevent the development of severe proteinuria and cGN. In Lc4, C57L/J derived heterozygosity reduces significantly the incidence for anti-dsDNA Ab and ANA production. In both heterozygotic and homozygotic Lc4 mice, severe proteinuria and cGN are seen in females have little ANA or anti-dsDNA antibodies. Thus the phenotypes of these congenic strains confirmed our linkage studies. In addition, the Lc1 mice do not have circulating ANA, anti-dsDNA and anti-histone Ab, suggesting the presence of a locus contributing to the production of these autoantibodies. This locus was named Adaz2. It was concluded that breaking tolerance to ANA and related autoantibodies is not required for the pathogenesis of lupus GN in NZM2328. These results support the thesis that autoimmunity as exemplified by ANA and related autoantibody production and end organ susceptibility to damage are under distinct genetic control. A less ANA-centric hypothesis was put forth (Figure 1). Figure 1. An interactive and less anti- nucleosome centric model for lupus pathogenesis: Autoimmunity and end organ resistance are interactive and play important roles in the induction of lupus nephritis. During the current funding period, we have concentrated our efforts on NZM.C57Lc1. We have characterized the recombinant strain Lc1R27, in which an 8Mb segment of chromosome 1 was transgressed from C57L to MZM2328. This region contains Cgnz1. Characterization of Lc1R27 show the homozygous female mice have little ANA and anti-dsDNA Abs and have acute GN (aGN) without progression to chronic GN (cGN). We have generated many additional recombinant lines by mating (Lc1R27XNZM)F1X(Lc1R27XNZM)F1. Two of them have been very informative. Lc1507-2 is resistant to the development cGN while Lc1290-2 is sensitive. These two lines define an 1.34Mb region on chromosome 1 that contains Cgnz1 and Adaz2. Preliminary data suggest that the podocytes of Lc1R27 are resistant to effacement caused by immune complexes. This small region corresponds to Sle1b containing 45 genes including those in the SLAM family. Microarray data and real time Q-PCR on glomeruli and kidneys isolated from Lc1R27 and NZM2328 identified several genes as candidate genes for end organ resistance. These data suggest that the SLAM family genes are likely controlling autoimmunity with ANA and anti-ds-DNA Ab production, while other genes are responsible for end organ resistance. In this next grant period, we intend to identify the genes within the 1.34 Mb region responsible for ANA and anti-dsdNA Ab production and for end organ resistance. The following specific aims are proposed. Specific Aim 1: To generate the NZM.C57Lc1 recombinant congenic strain Lc1(1.34Mb) that contains the 1.34Mb of interest by intercross breeding (NZM2328X507-2)F1 X (NZM2328X507-2)F1. A cohort of homozygous female mice of this new recombinant strain will be followed to 15 months of age to determine its phenotypes. It is expected that these mice will have aGN without ANA and related Abs and without progression to cGN. Experiments involving bone marrow transplantation will be performed to determine that gene(s) end organ resistance resides in the congenic strain Lc1(1.34Mb). Specific Aim 2: To identify a set of contiguous overlapping genomic clones (contigs) from the NZM2328 BAC library, which cover the 1.34 Mb region of interest and to sequence these contigs to define polymorphisms in this region by comparing the sequences with those of 129 and B6/C57L available in the database. The polymorphisms may also identify potential candidate genes for Cgnz1 and Adaz2. Specific Aim 3: To determine the transcriptional profiles of the 45 genes within this region in intrinsic kidney cells and in immune cells including T and B cells, dendritic cells, monocytes and macrophages and NK cells to identify candidate genes responsible for kidney resistance to damage and for those for enhanced autoimmune response. Specific Aim 4: To validate susceptibility by gene knockin technology or allele transgenesis. The expected results will provide conclusive evidence that genes controlling end organ damage play an important role in lupus nephritis and that they interact with genes that enhance autoimmunity resulting in various clinical presentations. These results will have significant clinical implications.